C-di-AMP signaling in S. aureus

Abstract
Staphylococcus aureus is a leading cause of human morbidity and mortality, causing infection of
the skin and soft tissues, post-surgical wounds, and lung infection among influenza and cystic
fibrosis patients. Widespread multi-drug resistance has made eradication of S. aureus
increasingly challenging, necessitating a deeper understanding of the physiology and
pathogenesis associated with these organisms. A key aspect of bacterial survival and adaptation
to altered environmental conditions is the ability to rapidly alter cellular behavior through second
messenger signal transduction. C-di-AMP has recently emerged as a key regulator of bacterial
physiology, pathogenesis, and immune activation. In the context of S. aureus, we believe that c-
di-AMP produced by S. aureus has three important roles; (i) as a signaling molecule that mediates
S. aureus metabolism and antibiotic resistance, (ii) as a bacterial PAMP that promotes
pathological inflammation and host susceptibility to bacterial infection, and (iii) as a mediator of
inter-bacterial signaling that alters the outcome of co-infections. Findings from these studies may
have significant impacts on the course of antibiotic therapy during S. aureus infection and may
uncover a novel target to eradicate recalcitrant S. aureus and the inflammation itpromotes.

Public health relevance
Project Narrative Staphylococcus aureus is a leading cause of human disease and is becoming increasingly recalcitrant to antibiotic treatment. By characterizing the mechanisms that contribute to S. aureus growth and pathogenesis, we aim to identify new targets for therapeutic intervention of many chronic and acute infections.